MOTOR NEURON DISEASE--A PROGRAM PROJECT

The goal of this Motor Neuron Disease (MND) Program Project Grant is to delineate principles underlying the selective vulnerability of the motor neuron. We plan to elucidate motor neuron-specific properties as well as factors that specifically act on motor neurons. The grant topics are: Core A - A clinical and pathological core that acts as a source of clinical information and specimens for members of the Program Project; the core also includes study of the characteristics of MND, the post- poliomyelitis syndrome, and medical ethical issues related to life- sustaining therapy in MND. Project #1 (Siddique) - An RFLP linkage study of familial MND. Project #3 (Gurney) - Neuroleukin (MND growth factor) and its relationship to MND survival and sprouting. Project #4 (Stefansson) Motor neuron-specific proteins and their relationship to motor neuron injury and neurite outgrowth. Project #5 (Roos) - Theiler's virus genes and gene products which determine neurotropism and neurovirulence.